Regulation of Protein Synthesis by Glucose

PROJECT SUMMARY/ABSTRACT
Skeletal muscle loss is associated with aging and various disease states. The mechanistic Target of Rapamycin
in Complex 1 (mTORC1) is a protein kinase that acts to upregulate skeletal muscle protein synthesis and thereby
promote muscle growth. Adenosine monophosphate-activated protein kinase (AMPK), a nutrient sensor, inhibits
mTORC1 during nutrient depletion and thereby inhibits cellular growth. Similarly, the Sestrin family of proteins
(Sestrins1-3) are leucine sensors that act to suppress mTORC1 by binding to and inhibiting the mTORC1
activating complex referred to as GAP activity toward Rags (GATOR2). Interestingly, the Sestrins bind not only
to GATOR2 but also AMPK, suggesting that they may mediate leucine-induced activation of mTORC1 through
multiple mechanisms. In novel preliminary studies presented herein, I show that the Sestrins mediate not only
leucine, but also glucose signaling to mTORC1. However, which of the three Sestrins mediates glucose-induced
regulation of mTORC1 is unknown. Moreover, whether glucose-induced activation of mTORC1 is mediated
through the Sestrin-GATOR2 complex and/or the Sestrin-AMPK complex is unexplored. Previous studies have
shown that AMPK is not only regulated by glucose but that it also regulates glucose metabolism, e.g. it
upregulates hexokinase 2 (HKII) expression, suppresses glycogen synthesis, and promotes glycogenolysis. In
novel preliminary studies presented herein, I show a specific interaction of Sestrin3 with AMPK and also show
that Sestrin3 associates with HKII. Based on these findings, I propose to test the hypothesis that glucose acts
through Sestrin3 and HKII to both stimulate mTORC1 activity and promote glycogenolysis. By using
knockdown and overexpression cell culture and rodent models as well as advanced microscopy
techniques I will elucidate the mechanisms through which glucose acts to modulate skeletal muscle
protein synthesis and glucose metabolism. It is anticipated that delineation of the molecular markers
associated with glucose-mediated stimulation of skeletal muscle metabolism will provide novel targets for future
studies as well as targets for pharmaceutical manipulation.

Public health relevance
PROJECT NARRATIVE Skeletal muscle loss is associated with increased morbidity, loss of function, and loss of autonomy. Although a plethora of studies have delineated many of the details of the mechanisms through which amino acids activate mTORC1 to stimulate muscle protein synthesis and, thus, improve skeletal muscle quality, essentially nothing is known about how glucose activates mTORC1. Understanding the mechanisms behind glucose-induced stimulation of muscle protein synthesis will not only complement the existing knowledge on the molecular mechanisms regulating muscle protein synthesis, but also provide further understanding of metabolism as a whole.